Molecular mechanisms of mtDNA inheritance

Project Summary
Mitochondrial DNA (mtDNA) encodes RNAs and proteins critical for cell function. However, pathways that
control mtDNA segregation and copynumber in mammalian cells are not well understood. The goals of this
work are to identify and characterize the unknown protein machinery that segregates replicating mtDNAs into
discrete nucleoid structures at ER-mitochondria contact sites and to describe the mechanisms and pathways
that regulate mtDNA copy number. The proposed experiments will provide fundamental insight into the
mechanism of mtDNA segregation and copynumber control, and how those processes are regulated,
potentially leading to the discovery and characterization of novel pathways that regulate the inheritance of
mtDNA disease haplotypes. In Aim 1, cutting-edge live-cell microscopy, proteomics, and high-throughput
sequencing technologies will be employed to dissect the molecular functions of mtDNA segrosome candidate
proteins identified in preliminary experiments. Aim 2 will address which cellular pathways are critical to
regulation of mtDNA copy number in human cells. This will be accomplished by systematic genome-wide
screens for modulators of mtDNA depletion recovery, single-cell RNA sequencing to cluster genes by their
transcriptional responses to mtDNA loss, and the characterization of candidate mtDNA copynumber effector
proteins in human cells depleted of mtDNA. These experiments will provide fundamental insight into the
mechanism of mtDNA segregation and copynumber control, and how those processes are regulated,
potentially leading to the discovery and characterization of novel pathways that regulate the inheritance of
mtDNA disease haplotypes.

Public health relevance
Project Narrative Mitochondria are endosymbiotic organelles that have their own genome and perform many essential functions in eukaryotic cells, including ATP synthesis via oxidative phosphorylation. Mitochondrial DNA (mtDNA) mutations cause heritable respiratory chain deficiency and contribute to a wide spectrum of diseases in humans, including metabolic disease, neurodegeneration, and cancer. The proposed research will elucidate mechanisms of mtDNA segregation and regulation in human cells and is relevant to the part of the NIH's mission that fosters fundamental basic cell biology discoveries that will directly lead to the identification of new therapeutic targets and therapies for the treatment of a wide array of human diseases.